SEER TRAINING WEBSITE AND CANCER PATHCHART TECHNICAL AND LOGISTICAL SUPPORT

SEER TRAINING WEBSITE, NEW DATA ITEM FEASIBILITY, ADVANCED TOPICS FOR CANCER REGISTRARS WORKSHOP, AND CANCER PATHCHART TECHNICAL AND LOGISTICAL SUPPORT